KUH-ART: Advanced Research Training in Kidney disease, Urology and Hematology

Summary of revised scope of work emanating from budgetary reductions: The percent effort for key personnel in leadership positions has been substantially reduced across all U2C grant components (Admin Core, Network Core, & Development Core). For some leadership positions, we will seek to secure modest institutional support to protect effort. We reduced GSR remittance fee in all five years for GSR on the evaluation team and in year 3 we removed the software license from the audiovisual team.

Public health relevance
Narrative Under a multi-PI leadership with a strong track record of scientific and mentorship collaboration, we propose a comprehensive regional interdisciplinary graduate and postgraduate training program (Kidney, Urologic, and Hematologic-Advanced Research Training or KUH-ART) to prepare trainees for long-term productive careers in advanced research in benign nephrology, urology and hematology. The overarching goal of the program is to recruit outstanding KUH trainees from diverse backgrounds and prepare them to lead multidisciplinary teams that produce KUH research with high impact on medical science and clinical outcomes. We benefit from exceptional resources: 1) our location one of the most creative and diverse metropolitan areas in the world, 2) UCLA, the top public University and its affiliates, and 3) relationships to elite research institutions including Caltech and RAND.